Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT: Biostatistics and Bioinformatics Core
The Biostatistics and Bioinformatics Core (B&B Core) is a cornerstone of the Harvard University Center for
AIDS Research (HU CFAR), consistently identified as one of the most important sources of value added. The
objectives of the B&B Core are closely linked to the overall CFAR mission: catalyze HIV research and enhance
the careers of Harvard-affiliated HIV investigators, with a particular emphasis on Early Career Investigators
(ECIs) and investigators Underrepresented in Medicine (URiMs) by providing biostatistics and bioinformatics
expertise for the planning, design, conduct, analysis, and reporting of HIV research (including laboratory,
animal, clinical, behavioral, prevention, outcomes, and implementation studies); assist in preparing grant
proposals; offer mentorship; and educate users in quantitative methods. The specific aims for the B&B Core
are: 1) Provide biostatistics/bioinformatics support for external and HU CFAR internal grant proposals. 2)
Provide biostatistics/bioinformatics assistance in study design and data analysis (whether part of a grant
proposal or not). 3) Provide database design assistance to ECIs/URiMs investigators considering the need for
future data sharing. 4) Provide user education in biostatistical and bioinformatics methods. 5) Provide
mentorship to ECIs and investigators who are URiMs. 6) Collaborate with and assist other HU CFAR Cores.